2020 Tissue Engineering and Regenerative Medicine International Society Americas Chapter (TERMIS-AM) Annual Meeting

The University of Michigan, the University of Toronto and the Tissue Engineering and Regenerative Medicine
International Society, Americas Chapter (TERMIS-AM) will be hosting and organizing the upcoming 2020
meeting of the TERMIS, Americas Chapter (TERMIS-AM) Conference and Exposition. Michigan is requesting
support for travel awards for the Student and Young Investigator Section (SYIS) as well as women researchers
and trainees to attend the full conference. The conference will be rigorously publicized to attract women and
underrepresented minorities, with particular focus on historically black universities and medical schools, as well
as individuals with disabilities. Additionally, each scientific session to be presented at the conference was
asked to include a statement on how diversity, equity and inclusion will be considered when selecting speakers
and student engagement. The theme of the conference and the highlight of the meeting is “Synergizing to New
Heights in Health.”

Public health relevance
Narrative The field of regenerative medicine has the potential to improve human health by providing new approaches and technologies to restore damaged and diseased tissues. The field is moving forward quickly and will have a substantial impact on human health and the TERMIS 2020 meeting will emphasize this impact of regenerative medicine on people’s lives. With the location of the meeting at the birthplace of stem cells (Toronto, CA), the meeting will remember previous accomplishments and look forward to new techniques and vistas for impactful translation. The preconference symposia will focus on strategies for accomplishing translational research and bringing regenerative medicine therapies to the clinic.